Developing a Biomimetic Lactating Mammary Lobe for Therapeutic Safety

PROJECT SUMMARY.
Breast milk is rich with bioactive components that are critical to an infant’s development. It is highly recommended
that infants ingest breast milk; but, fluctuating maternal hormones and substandard post-parturition health
directly mediate breast milk production. Maternal ingestion of small molecule drugs further compounds
decreased breast milk synthesis and secretion, and adversely compromises breast milk quality. Although the
majority of actively breastfeeding women consume medication or receive therapeutics, small drug molecule
transport from maternal plasma to synthesized breast milk remains largely unknown. Important strides in
understanding pharmacokinetics in milk-producing mammary glands have yet to occur because of the lack of
engineered bioinspired mammary lobe systems that mimic complex in vivo signatures— topographical lobule
microcurves, spiked levels of lactogenic hormones, cellular landscapes, and mechanically-driven lobe expansion
and contraction. The objective of this proposal is to determine if our established microengineered mammary lobe
system, which integrates key physiological characteristics, i.) faithfully mirrors multifactorial breast milk synthesis
processes and ii.) could be employed as a versatile screening testbed for evaluating drug and therapeutic safety
during lactation. The project is based on the central hypothesis that exogenous stimuli that reflect in vivo
mechanisms, such as hormone levels, dynamic mechanical lobe stimulation, and passive transport of small drug
molecules, will potentiate differential cellular landscape phenotypes and lead to unique content differences in
engineered breast milk. This could develop a new in vitro preclinical model that promotes the cognizance of
drugs or therapeutics that are safe to ingest or receive during lactation. We believe this contributes to improving
important women’s health issues. Our hypothesis will be tested through the following two aims. Aim 1 will develop
a 3D mammary lobe model and determine how in vivo relevant parameters alter physical and molecular
mammary cell phenotypes, and regulate the secretion of important breast milk components. Aim 2 will investigate
the pharmacokinetics of small molecule drugs or therapeutics that passively diffuse into the engineered breast
milk. Nicotine or mRNA encoding for SARS-CoV-2 will serve as a model drug or therapeutic, respectively. We
will pursue these aims using an innovative combination of analytical and adaptable techniques from engineering
and biological sciences. These include the development of a scalable lobe model, by which the application of
physiologically relevant stimuli and compartments can mimic breast milk synthesis and drug distribution. The
engineering approaches that we leverage will develop foundational resources for the ongoing efforts and
research revolving lactation and post-parturition health equity. The expected outcome of this work will highlight
the importance of engineering new microsystems for in vivo mimicry. These platforms can facilitate clinical
translation of rapid drug and therapeutic safety screening. The results will have a significant positive impact to
women and will encourage the ongoing efforts to support women during their breastfeeding journey.

Public health relevance
PROJECT NARRATIVE. The proposed research is relevant to public health because we present a new bioinspired mammary lobe model that faithfully recapitulates topographical microcurved lobules, cellular landscapes, critical lactation-related hormone levels, and dynamic mechanical motion for in vivo mimicry of milk producing glands. The microengineered system contributes to women’s health research by serving as a versatile preclinical drug or therapeutic screening testbed to evaluate small molecule drug pharmacokinetics from maternal plasma to breast milk and to assess drug compatibility during breastfeeding. This proposal is relevant to the greater NIH mission that supports fundamental and innovative research strategies as a basis for advancing maternal health equity and reducing pregnancy-associated complications across the nation.